ADOLESCENT STRESS &COPING: A DEVELOPMENTAL PERSPECTIVE

Epidemiological trends reflecting adolescent stress reveal an alarming rise over the last decade, including suicide and homiocide rates, juvenile arrests, and unplanned teen-age pregnancies. Efforts to address these problems have been hindered by a lack of research on adolescent stress which incorporates our increasing understanding of adolescent development as well as contemporary models of stress and coping. Past large scale prevention and intervention programs for adolescents have not capitalized on recent findings regarding the efficacy of cognitive coping mechanisms for moderating stress; rather, they have utilized more traditional group counseling approaches. This is a function of lack of knowledge regarding the nature of the interaction between the cognitive changes of adolescence, as they impact upon identity formation, and the development of stress and coping. This study is designed to gain a better understanding of how cognitive changes in adolescence increase or reduce stress, and contribution to the development of coping skills. Two interviews will be conducted with 480 male and female adolescents from three demographic sub-samples and four different age groups. The first interview will probe the subjects' own perceptions of stressors in their environment and coping mechannisms they use. The second phase of interviewing will follow more traditional semi-structured procedures to assess identity status. Discourse analysis of the full transcripts will assess the cognitive developmental label of subjects. Finally, subjects will directly rate the stressfulness of particular items and the effectiveness of coping mechanisms derived from prior research. The overall goals of the investigation are to contribute to a more naturalistic understanding of the important stressors affecting adolescents, to evaluate the prevalence and effectiveness of various coping mechanism, to understand their development, and to support the design of more effective stress intervention and prevention programs for adolescents.